Mechanism of macrophages colonization in gonorrhea

ABSTRACT
The work proposed in this study seeks to investigate the role of macrophages colonization by Neisseria
gonorrhoeae (Ng) during infection and the impact on gonorrhea development. Because Ng is a highly human-
adapted pathogen, it has developed numerous mechanisms to avoid and actively suppress innate and adaptive
immune responses. We uncovered that Ng colonizes and establishes topologically distinct colonies in
macrophages. During colonization, Ng manipulates the actin cytoskeleton to invade and create an intracellular
niche supportive of bacterial replication. This new model of Ng persistence in macrophages is significant for
gonorrhea symptomatology and outcome since the relevant cellular reservoir of bacteria during in vivo infections
has yet to be identified. Here we will uncover (1) the host receptors required for macrophages colonization by
Ng; (2) bacterial adhesins involved in macrophages colonization; and (3) the role of macrophages colonization
by Ng in the context of mucosal immunity in gonorrhea human samples.

Public health relevance
Project Narrative Understanding the molecular links that control the intricate relationship between Neisseria gonorrhoeae and the cells of the innate immune system, in this case - the macrophages, is critical for novel therapy design against this highly antibiotic-resistant pathogen. The knowledge gained will provide important insight into how Neisseria manipulates the host receptors and actin polymerization machinery to invade and form a replicative niche and ultimately will aid in the design of more effective therapeutic strategies.